Metabolic Biomarkers of Response of Mantle Cell Lymphoma to Bruton Tyrosine Kinase Inhibition

Metabolic Biomarkers of Response of Mantle Cell Lymphoma to Bruton Tyrosine Kinase Inhibition
Project Summary/Abstract
Due to increased application of kinase inhibitors to cancer therapy, there is a need to develop noninvasive ear-
ly detection methods to monitor the activity of treatment in patients. We aim to develop methods to address
three critical issues – 1) early detection of tumor response or resistance to therapy, particularly by noninvasive
imaging techniques, 2) defining detailed mechanisms of drug response and resistance, and 3) using this infor-
mation to overcome drug resistance. Noninvasive in vivo monitoring of cell signaling pathways is not feasible,
and monitoring of changes in tumor volume is a late and often misleading response indicator. FDG PET, while
ideal for tumor detection is not response predictive, likely because it evaluates only the first two steps of the
glycolytic pathway, while tumors are able to use other pathways to process nutrients required for their growth.
We propose a novel alternative – to detect response by monitoring the key metabolic pathways regulated by
the kinase inhibitor. Our basic premise is that changes in tumor metabolism are earlier and more reliable indi-
cators of therapeutic response than changes in tumor volume. We focus on the Bruton's tyrosine kinase (BTK)
signaling pathway using an FDA-approved BTK inhibitor, ibrutinib (IBR), as well as two second-generation in-
hibitors of mantle cell lymphoma (MCL). We propose to use a comprehensive genomic/phospho-
proteomic/metabolomic approach to delineate the mechanism of response and resistance to BTK inhibition. In
preliminary studies we have evaluated index MCL cell lines, one of which (MCL-RL) is highly sensitive to IBR
and another (JeKo-1) is resistant. Preliminary RNA-Seq analysis indicates that BTK modulates expression of
many genes involved in key metabolic pathways including glycolysis, the pentose shunt, TCA cycle and glu-
taminolysis. By measuring metabolic flux through these pathways before and after treatment with IBR, we will
determine which of these pathways are critical to response and resistance. We found that in JeKo-1 cells glu-
taminolysis is critical to IBR resistance and can be overcome with glutaminase inhibitors. We have developed
and validated novel 13C MRS and 13C LC-MS methods to monitor flux through key pathways of tumor metabo-
lism and propose to use these methods on the MCL models in in vitro and in vivo studies to define the mecha-
nism of response and resistance to the drug. Lactic acid, alanine and choline have emerged as potential meta-
bolic biomarkers of response of MCL cells to BTK inhibition that can be monitored by 1H MRS using the Had-
Sel-MQC pulse sequence developed by us. In Aim 1, we will perform genomic and metabolomic studies of re-
sponse and resistance to BTK inhibition in cell lines and primary cells derived from MCL patients. In Aim 2, we
will utilize in vitro 1H MRS and 13C MRS and LC-MS to verify and quantitate perturbations of metabolic fluxes in
pathways identified in Aim 1 as potential imaging biomarkers of BTK inhibition. Finally, in Aim 3 we will utilize
1H, 13C & 31P MRS imaging and LC-MS analysis in mouse xenografts of MCL to validate the metabolic bi-
omarkers of BTK inhibition identified in Aims 1 & 2.

Public health relevance
Metabolic Biomarkers of Response of Mantle Cell Lymphoma to Bruton Tyrosine Kinase Inhibition Project Narrative We are developing a novel method for noninvasive detection of response of human mantle cell lymphoma (MCL) to a new class of drugs, inhibitors of Bruton's Tyrosine Kinase, two of which, ibrutinib (IBR) and acalabrutinib, have recently been approved by the FDA for MCL, chronic lymphocytic leukemia (CLL), marginal zone lymphoma and also evaluated for other types of lymphoma. We are developing magnetic resonance imaging and spectroscopy (MRI/MRS) methods that detect changes in tumor metabolism resulting from BTK inhibition. Our preclinical studies will pave the way for applying MRI/MRS-based tumor imaging to patients with a broad spectrum of cancers treated with diverse kinase inhibitors.